Utilizing tobacco discrete choice experiments to predict the population impacts of FDA regulatory policies

PROJECT SUMMARY
As the state-of-the-art method to assess consumers’ preferences for new products, discrete choice experiments
(DCEs) have been increasingly applied to study the impacts of potential policies on tobacco use behaviors,
particularly in the areas of product standards and messaging development (e.g., warnings and campaigns).
Compared to observational survey data, DCEs have the advantage of providing nimble evidence on emerging
products with low prevalence and predicting the impacts of potential policies on behaviors before they are
implemented in the real world. However, their potential in guiding and defending FDA policies has not been fully
realized due to several methodological challenges. The first challenge is the lack of consistency in tobacco DCE
design and reporting. Researchers often adopt different design features (e.g., whether to include an opt-out
option) and use different measures in reporting, such as willingness to pay (WTP) vs. relative importance scores.
Therefore, it is important to review current practices, explore how to synthesize existing DCE evidence, and
propose guidelines for future DCE design and reporting. The second challenge is hypothetical bias – the bias
between stated preferences (SP) or “what people claim that they would do” and revealed preferences (RP) or
“what people actually do in the real world.” Recent method development has combined DCEs and RP data (e.g.,
retail and survey data) to mitigate hypothetical bias, providing us a unique opportunity to revisit existing DCEs
and improve their accuracy in policy impact prediction. The overarching goal of this project is to inform the
impact of FDA regulatory policies on tobacco use behaviors using existing DCE evidence. We will conduct
systematic reviews to synthesize evidence on product standards and messaging development by assessing the
ranking of policy importance and WTP. Moreover, we will combine existing DCEs with Nielsen Retail Scanner
data and nationally representative surveys to mitigate the hypothetical bias in DCEs, which improves the
accuracy of using existing data to predict the impact of potential regulatory policies that have not been
implemented yet. The specific aims are to 1) Conduct a systematic review of tobacco DCEs manipulating
product attributes. 2) Conduct a systematic review of tobacco DCEs manipulating product messaging. 3)
Combine stated-preference DCEs and revealed-preference real-world retail and survey data to predict the
impacts of FDA regulatory policies on product market shares and tobacco use. This project will provide the first
systematic review of tobacco DCEs in the context of informing FDA regulatory policies, further improving the
accuracy of DCE in predicting policy impacts. In summary, this project uses existing data to address priority
scientific domains of RFA-OD-21-003, including tobacco product characteristics, communication practices, and
tobacco use patterns.

Public health relevance
PROJECT NARRATIVE As the state-of-the-art method to assess consumers’ preferences for new products, discrete choice experiments (DCEs) have been increasingly applied to study the impacts of potential policies on tobacco use behaviors, particularly in the areas of product standards and messaging development (e.g., communication and campaigns). The overarching goal of this project is to conduct systematic reviews and synthesize DCE evidence on product standards and messaging development, further combining existing DCEs with Nielsen Retail Scanner data and nationally representative surveys to improve the accuracy of policy impact prediction by mitigating hypothetical bias in DCEs.